A developmental mechanism of temperature-sensitive seizures towards therapeutic manipulation

PROJECT SUMMARY
Febrile seizures are the most common type of seizure, occurring in 2-4% of all children. Incidence is between 6
months and 3-5 years of age, with a peak between 12-18 months; yet, febrile seizures mysteriously vanish in
childhood. While most febrile seizures are benign and self-limited, prolonged febrile seizures are a known risk
factor for future epilepsy and can in rare cases be fatal, due to febrile status epilepticus or sudden infant death.
Despite the importance of the issue and decades of investigation, a unifying theory has yet to emerge as to the
basic mechanism of febrile seizures. Further insight could lead to the development of novel strategies to prevent
recurrent febrile seizures in otherwise healthy children and in epilepsy syndromes characterized by recurrent
febrile seizures (such as Dravet syndrome), and to anti-epileptogenic therapies after prolonged febrile seizure
that could decrease the frequency of temporal lobe epilepsy.
This collaborative application employs a comprehensive and multidisciplinary approach and newly-generated
tools to test the hypothesis that febrile seizures involve the temperature-dependent failure of action potential
generation by a defined subset of GABAergic inhibitory interneuron during a specific developmental window due
to a specific vulnerability conferred by a changing balance of sodium and potassium conductances.
Proposed experiments will determine the temperature sensitivity of action potential generation and propagation
by subsets of GABAergic inhibitory interneurons and excitatory principal cells across relevant brain areas, using
biologically-informed computational models to validate experimental findings and generate testable hypotheses
(Aim 1). We will demonstrate the same cell type-specific failure during temperature-induced seizures in mice in
vivo using two-photon calcium imaging and large scale multiunit electrophysiological recording with Neuropixel
probes (Aim 2). Then, we will attempt to attenuate or prevent temperature-sensitive seizures via gene transfer
(Aim 3.1) and targeted pharmacotherapy, to rebalance interneuron excitability during this vulnerable
developmental window (Aim 3.2).
Completion of the proposed experiments will provide novel information as to the developmental trajectory of
sodium and potassium ion channel expression as well as the temperature sensitivity of key subtypes of cerebral
cortex neurons, to define a novel mechanism of temperature-sensitive seizures across physiologically-relevant
experimental models. Such results could drive development of novel treatments or preventative measures for
febrile seizures that could reduce associated morbidity and mortality and the future emergence of temporal lobe
epilepsy.

Public health relevance
PROJECT NARRATIVE Febrile seizures are the most common seizure type, seen in 2-4% of all young children, yet mysteriously disappear by age 3-5 years. Febrile seizures are not necessarily benign, as prolonged febrile seizures have associated mortality and are a risk factor for future epilepsy; however, despite the significance of this clinical entity, a unified theory as to the mechanism of febrile seizures has yet to emerge. The main hypothesis of this proposal is that febrile seizures involve the temperature-dependent failure of action potential generation by a defined subset of cerebral cortex GABAergic inhibitory interneuron during a vulnerable developmental window due to a specific and shifting balance of cell type-specific ion channels mediating interneuron excitability.